500 MHz NMR Spectrometer

Wayne State University (WSU) proposes to acquire a nuclear magnetic resonance (NMR) spectrometer to characterize the molecular structure of biomedically relevant organic, organometallic, and polymeric molecules. This critical technology will enable over eight faculty members to accelerate medical research involving synthesis, inter- and intra-molecular interactions, and reaction mechanisms. New instrumentation is needed to replace a 28-year old unshielded Varian 500 MHz NMR spectrometer, whose platform is now obsolete. The modern capabilities of the proposed 500 MHz NMR spectrometer will greatly enhance the progress of biomedically motivated research projects at WSU. This instrument will be used to characterize (1) ligands for contrast agents for magnetic resonance imaging, (2) contrast agents for magnetic resonance imaging, (3) hyperpolarization agents to probe cellular metabolism, (4) custom 13C-labeled compounds for biomedical studies, (5) novel analogs of adenosine 5' triphosphate and inhibitors of histone deacetylase, (6) the diastereoselectivity of glycosylations, (7) mechanistic pathways in allylic fluorination and nickel-promoted glycosylation reactions relevant to imaging and diseases, (8) new chemical probes and agents to analyze proteins relevant to pathological diseases, (9) small-molecule natural products, (10) photoactivated drug candidates, and (11) the synthetic steps involved in making polycyclic alkaloids, cyclic polypeptides, and glycoproteins for disease applications. The new instrument with a new capability to perform 1H{19F}, 19F{1H}, and 1H?19F correlation experiments will greatly enhance productivity toward the goals of several NIH-funded projects and enable those projects to take on new directions. For example, the proposed instrument will provide an active platform to enable the exchange of pulse sequences and experiments with collaborators to advance the research at WSU beyond its current capabilities. The proposed spectrometer will reduce cryogen and energy consumption and is expected to maximize the returns of many other investments of the NIH through enabling new advancements in small-molecule drug discovery, imaging probe development, and carbohydrate and peptide chemistry of the NIH-funded major users.

Public health relevance
The acquisition of the proposed 500 MHz NMR spectrometer will accelerate research already funded by the National Institutes of Health in the areas of imaging of hypoxia, cancer detection, contrast agents for magnetic resonance imaging, peptide synthesis, medically relevant inhibitors, and protein and carbohydrate modification. Consequently, this project is particularly relevant to the NIH's mission to protect and improve health.